ChicAgo Center for Health and EnvironmenT (CACHET)

PROJECT SUMMARY – Overall
This is the revised submission of the first competing renewal proposal for the “ChicAgo Center for Health and
EnvironmenT (CACHET)” – the first NIH P30 Environmental Health Sciences (EHS) Core Center in the
Chicago area established in 2017 with an equal partnership between the University of Chicago (UofC) and the
University of Illinois at Chicago (UIC). With synergistic partnership between the two universities with
complementary strengths, CACHET promotes multidisciplinary EHS research among clinician, laboratory, and
population scientists to evaluate, delineate, and ultimately reduce environmental health related risks among
residents of Chicago and beyond. The continuation of a dedicated EHS research center in Chicago is
warranted by deep- rooted environmental conditions and their associated health outcomes across population
sub- groups. In this context, the CACHET mission is to understand how environmental exposures in urban
settings affect human biology and health. Our goal is to generate actionable scientific knowledge that supports
efforts to reduce chronic disease burden and improve population health. While there was some EHS research
at both institutions prior to the establishment of CACHET; over the past 3.5 years, CACHET has integrated this
research, brought researchers together, formalized and steered intra- and inter-institutional collaborations, and
significantly enhanced EHS research support infrastructure in the Chicago area. Specifically, CACHET has
established Biomarkers and Microbiome Cores, a dynamic Pilot Project Program (PPP), a vibrant Community
Engagement Core (CEC), and a highly translational Integrated Health Sciences Facility Core (IHSFC) – all new
to the Chicago area. Within this short time frame, and despite the recent pandemic, CACHET has made
positive impacts on interdisciplinary and inter-institutional collaborations, multi-sectorial partnerships among
community/city/state agencies, and translational EHS discoveries. Leveraging our progress and lessons
learned so far, and responding to reviewers’ critique of our first resubmission, we are moving forward by i)
streamlining CACHET focus group structure to improve interactions, synergy, and translation, ii) better
leveraging the UofC- UIC complementarity and institutional infrastructure to maximize CACHET efficiency, iii)
responding to the P30 RFA new emphasis on translational EHS research, and, iii) addressing NIEHS strategic
mission. We have revamped the CEC with new leadership and a community-focused agenda; we formed a
“Environmental Biomarkers Core (EBC)” by merging the previous ‘Biomarkers’ and Microbiome’ Cores with
enhanced access to other institutional Omics Cores (not funded by CACHET); we refined the IHSFC to
augment its services to access and leverage large cohorts established and led by CACHET members; and we
have taken initiatives to broaden EH research capacity in Chicago through pilot projects and tailored career
development.

Public health relevance
ChicAgo Center for Health and EnvironmenT (CACHET)”, the first NIEHS P30 environmental health sciences core center in the Chicago area, was established in 2017 as a collaboration between the University of Chicago and University of Illinois at Chicago. Leveraging the experience and progress made over the past 3.5 years, CACHET will continue to promote multidisciplinary environmental health research among clinician, laboratory and population scientists from two Chicago area universities with complementary strengths and structure to understand, evaluate and ultimately reduce the impact of harmful environmental exposures on health outcomes in the region and beyond.